Investigating the Role of Apoptosis in Early Life Vulnerability to Lead-Induced Neurotoxicity

PROJECT SUMMARY/ABSTRACT
The public health crisis in Flint, Michigan has resurfaced concerns about exposure to lead, a neurotoxicant that
causes long-term brain damage in children. Despite its known dangers, the biological mechanisms that make
children more vulnerable to exhibiting neurocognitive impairments after lead exposure remain unknown.
Apoptosis regulation is one potential mechanism, as neurodevelopment requires apoptosis to prune
superfluous neurons and lead has been shown to trigger apoptotic cell death. Our laboratory has recently
discovered that neural cells are “primed for apoptosis” during the postnatal brain maturation period. The pro-
apoptotic protein BAX, which causes mitochondrial permeabilization and cytochrome c release to initiate
apoptosis, facilitates this sensitivity. More mature neural cell types are less prone to apoptosis as BAX
expression decreases with age. We believe that heightened BAX expression and apoptotic priming in the
young brain drive lead-induced apoptosis and consequent neurocognitive impairments, which may be
prevented by blocking apoptosis. This F31 research proposal aims to determine if suppressing BAX-mediated
apoptosis in neural cell populations can reduce the neurotoxic effects of early-life lead exposure and improve
neural cell survival and function. Our central hypothesis is that lead induces pro-apoptotic signaling in the brain
regardless of age, but young brain tissue is more likely to exhibit signs of neural cell apoptosis due to higher
BAX expression and apoptotic priming than adults, increasing vulnerability to neurocognitive impairment. I
proposed to test this in three aims: (1) elucidate the mechanism of lead-induced neural cell apoptosis in
differentiating human and mouse cells; (2) investigate how the timing of initial lead exposure during
development affects the developing brain; and (3) investigate how BAX knockout protects against
neurocognitive impairments. My training plan aims to help me achieve my short-term career goal of attaining a
prestigious postdoctoral fellowship, which, upon completion, would prepare for my long-term goal of
establishing my laboratory as a tenure-track professor at a high-ranking school of public health, where I aspire
to conduct research in developmental neuroscience and environmental neurotoxicology. Therefore, I am eager
to contribute to manuscripts, publish first-author papers, and share my discoveries in seminars series and at
national conferences. I am also committed to modest amounts of teaching, curriculum development, outreach,
and mentoring other students. I understand that these goals are not easily achieved and am grateful for the
support offered by my sponsors and the members of my Science Advisory and Career Mentoring Committees.
Working together, we have the potential to achieve significant progress in the areas of cell death,
neuroscience, public health, and environmental health.

Public health relevance
PROJECT NARRATIVE Lead is an environmental neurotoxicant that causes irreversible cognitive impairments and disproportionately affects socially disadvantaged communities. Despite the clear epidemiological data demonstrating that children are more sensitive to the neurotoxic effects of lead exposure at a population level, the biological mechanisms linking childhood lead exposure and cognitive impairment are unclear. Our studies will test the extent to which development-associated changes in regulation of apoptosis (programmed cell death) drive lead-induced neurotoxicity and how it can be targeted for neuroprotection.